PREVENTION OF DENTAL CARIES

DESCRIPTION (adapted from the Investigators' abstract): This application has the goal of providing more efficacious fluoride (F) treatments for preventing or reversing caries and desensitizing dentin, than current consumer and professional products. The overall hypothesis is that two-component reactant systems can form the basis for superior dental treatments that operate by efficiently removing fluoride, phosphate and calcium ions from solution and ge vehicles and depositing them within dental tissues. This approach is proposed as being capable of enhancing caries protection at a given level of fluoride exposure, and producing long-lasting tubule obturation to desensitize teeth. The basic strategy is to utilize separate components that react to efficiently precipitate and remove a high proportion of mineral ions from solution, and to control the rate of precipitation so as to facilitate permeation of the reactants into dental hard tissues and the deposition of large amounts of insoluble mineral within carious lesions or dentinal tubules. Five specific aims are proposed, each of which will involve three to four related studies. Aim 1. In vitro and intraoral determination of the remineralization potential of two-component, reduced fluoride rinses and dentifrices. Aim 2. Intraoral evaluation of the anticaries effect of a remineralizing gel material to be placed interproximally, and development and in vitro evaluation of a similar thermo-plasticized gel material as a pit and fissure anticaries treatment. Aim 3. Intraoral evaluation of the anticaries effect of a remineralizing chewing gum; and in vitro development and in vivo testing in a pilot clinical trial of calcium (Ca)- and phosphate-releasing chewing gum for tubule obturation and desensitization. Aim 4. Development, in vitro testing, and pilot clinical evaluation of a two-step topical treatment for desensitizing dentin by obturation of tubules with insoluble Ca-phosphate products. Aim 5. Study of chemical and physical mechanisms of two-component phosphate chemistry systems that have potential to control the deposition of insoluble Ca, F and phosphate compounds within dental tissues.